Investigating the IL-1R Pathway in Anaplastic Large Cell Lymphoma for Targeted Therapy

PROJECT SUMMARY
Anaplastic large cell lymphoma (ALCL) comprises a collection of mature T-cell neoplasms that share elevated
expression of CD30 and anaplastic cytology. ALCL subtypes are divided into two classes based on the status of
anaplastic lymphoma kinase (ALK), ALK+ and ALK-. While ALK+ ALCL is relatively homogeneous, ALK- ALCL
represents a heterogeneous group comprising systemic ALK negative and primary cutaneous ALCL (pC-ALCL).
The recently recognized breast implant-associated (BIA) ALCL, which arises in the seroma cavity surrounding
breast implants, was acknowledged as a distinct clinical and pathological entity that shares morphologic features
with ALK- ALCL. Current therapeutic strategies for ALCL are largely based on aggressive B-cell lymphoma
regimens. However, the outcomes are generally much worse in patients with ALK- ALCL than in those with ALK+
ALCL. Thus, there is a need to develop novel, preferably small molecule-based targeted therapies for these
lymphoid malignancies, especially in ALK- and BIA ALCL cases. A major barrier to this goal is the lack of a
systematic and comprehensive understanding of the deep molecular characteristics of ALK- and BIA ALCL
pathology, which is clearly needed in order to identify critical therapeutic vulnerabilities. To address the gaps in
knowledge, we applied an unbiased high throughput CRISPR screening in ALCL, and identified an unexpected
role of the IL-1R-MyD88 pathway in supporting ALK- and BIA ALCL. The IL-1R signaling pathway is a key
mediator of immunity and inflammation and has been shown to play a critical role in many solid tumors; however,
its role in lymphoid malignancies has not been established. Indeed, our preliminary studies provide the first
unequivocal evidence that IL-1R1 pathway plays an essential role in supporting ALK- and BIA ALCL cell survival.
Clinically, we found that IL-1 receptor and IL-1α expression are consistently elevated in primary ALK- cases, and
this is correlated with IL-1R signaling activation (p-IRAK4 level) in primary samples. Moreover, using RNA-seq
analysis, we identified a set of IL-1R pathway regulated genes in ALK- ALCL that overlapped significantly with
signatures reflecting JAK-STAT3 activity and TH17/TH1 phenotyping. Finally, a highly specific IRAK4 inhibitor
shows promising activity against ALK- and BIA ALCL in vitro and in a mouse xenograft model. Altogether, these
findings provide strong support for our hypothesis that the IL-1R pathway promotes ALK- and BIA ALCL
pathogenesis, and that targeting this pathway could be a novel therapeutic strategy in these diseases. In this
study, we will test our hypothesis through the following aims: 1) Elucidation of the exact role of IL-1R pathway in
ALK- and BIA ALCL, 2) Understanding of mechanisms regulating this pathway and its relationship to recurrent
genetic lesions in ALCL, and 3) Validation of the IL-1R pathway as a novel therapeutic target in these
malignancies. The proposed studies should provide critical insights into the molecular circuitry that drives these
types of ALCL and, consequently, result in the development of novel targeted therapeutic strategies for these
distinct lymphoproliferative disorders.

Public health relevance
PROJECT NARRATIVE (RELEVANCE TO PUBLIC HEALTH) This study is aimed at investigating in detail the pathogenic role of IL-1-driven inflammatory pathway in anaplastic large cell lymphoma (ALCL). Gaining insight into the mechanisms activating this inflammatory pathway in ALCL as well as its exact involvement in the malignant cell transformation may lead to improved understanding of the molecular circuitry that drives tumor survival and shapes the tumor microenvironment. The therapeutic potential of targeting the pathway will be tested using a specific kinase inhibitor and a recombinant inhibitory protein, which may lead to novel strategies for targeted therapy in this unique group of lymphoid malignancies.